Mentoring Core

Mentoring Core Project Summary/Abstract
The mentoring core, to date, has provided support and advice to over 1,100 undergraduate
student researchers, including 198 on the campuses of the TCUs. Student graduation rates
have been very high, with impressive entry of students into research and the health
professions. The goal of the mentoring core is to continue this success and to further stimulate
the entry of American Indian students into research and the health professions. A new
program, shown in a preliminary study to increase student authorship on peer reviewed
publications, will continue to be pilot tested by the mentoring core. The mentoring core is also
initiating a new program to assist the TCU’s teaching and research by providing a postdoctoral
fellow on each campus for one semester each year. This initiative was suggested by the
leadership of the TCUs and readily adopted by the mentoring core. The mentoring core has
also established a new postgraduate M.S./Ph.D. program in clinical translational science. It is
designed to promoted postgraduate opportunities for students in the ND INBRE network. It is
designed to provide enhanced one-on-one interaction between faculty and students. The
mentoring core will continue to provide “hands-on” workshops as requested by the ND INBRE
partners.